Role of Th17 in Severe and Recurrent C. difficile Infection

Project Summary
Introduction: We propose to Identify the mechanisms by which an intestinal Th17 immune response
contributes to severe and recurrent Clostridioides difficile infection (CDI) and explore the immune
mechanism by which fecal microbiota transplant (FMT) protects.
Hypothesis: Th17 cells contribute to severe CDI and to recurrence.
Premise: Failure of antibiotic treatment of CDI (i.e. death or recurrence) is due to a gut Th17 immune
response.
Significance: C. difficile is the leading cause of hospital-acquired infection in the United States. One in five
patients with CDI fails antibiotic treatment and as a result suffers a recurrent infection or death. This proposal
will explore if immunotherapy would improve treatment of CDI, specifically by testing the importance of gut
Th17 immune responses in CDI severity and recurrence
Investigators: Dr. William Petri at the University of Virginia has discovered that Type-17 immunity causes
more severe disease during CDI. This has included showing that IL-23 knockout mice have increased
survival, reduced neutrophil influx, and reduced tissue pathology (Buonomo et al 2013), that the Th17
polarizing cytokines IL-6 and IL-23 are associated with more severe disease in humans, that type 2
immunity protects by countering Th17 (Frisbee et al 2019), and that adoptive transfer of Th17 cells is
sufficient to enhance CDI mortality (Saleh et al 2019). He is joined by Dr. Ann Hays who directs the
complicated C. difficile clinic at UVA and the biostatistical expertise of Dr. Jennie Ma.
Innovation: The proposed research by testing if Th17 cells have a role in severe CDI as well as recurrent
CDI will be paradigm shifting, as this is a field of research that in the past has focused on targeting the
bacterium or the microbiota for therapy. This proposal will instead test if the induction of a Th17 immune
response in addition to the bacterium and microbiota are causing disease.
Approach:
Specific Aim 1: SEVERE CDI - Identify the mechanisms by which a Th17 immune response leads to severe
C. difficile infection (CDI)
Specific Aim 2: RECURRENT CDI - Test the role of Th17 cells and the Th17-recruiting chemokine CCL5 in
recurrent CDI
Specific Aim 3: FMT – Determine if FMT protects from primary and recurrent CDI by inducing IL-33 that
blocks the action of Th17.
Environment: Key to success are the complementary expertise of the Petri lab in the mucosal immunology
of enteric infections, and the clinical expertise in FMT for complicated C. difficile infection of Dr. Ann Hays.

Public health relevance
Narrative Clostridioides difficile infection (CDI) is the most common hospital acquired infection in the US and has been designated by CDC as one of the five antimicrobial resistance most “Urgent Threats” to public health. Failure of antibiotics to cure CDI we hypothesize is due to an immune response of patients to CDI that causes more harm than good. We propose to test if treatment can be improved by blocking the damaging immune response.